Core C: Bioinformatics and Genomics Core

Project Summary/Abstract – Core C
Bioinformatics has become an integral part of biological research due to the high-throughput nature
of multi-omics experiments warranting the need for having the infrastructure and trained personnel
to support the advancement of science of the research projects. The Bioinformatics and Genomics
Core (Core C) will continue to serve as a linchpin in the overall success of the program project by
supporting the generation, storage, processing, analysis and accessing of experimental data. Core
C will be led by Drs. Babu Guda and James Eudy, who will provide complementary expertise in
Bioinformatics and Genomics areas, respectively. This Core is innovative by having a fully integrated
Bioinformatics as well as Genomics units within, which allows full spectrum access to cutting-edge
experimental and analytical techniques under one Core. The specific aims are: Aim 1: Support the
sequencing and analysis of multi-omics data for research projects. Aim 2: Integrative analysis and
functional characterization of significant genes, gene products, enriched pathways, and upstream
regulators for hypothesis generation and testing. Aim 3: Develop a web portal to centralize access to
multi-omics data from all research projects and to facilitate bioinformatics training activities. Core C will
make a big impact on the overall success of the project by providing resources, personnel support and
developing cutting-edge technologies and custom data analysis methods for all research projects.
Proposed cloud-based web portal backed by a searchable database provides easy access to all
experimental data, metadata, and the training materials facilitating synergistic interactions among the
project personnel across multiple sites.